Impact of Pediatric Atopic Dermatitis on Neurocognitive Function

PROJECT SUMMARY / ABSTRACT
The overall objective of this K23 application is to provide support for the additional training and experience that
Dr. Joy Wan, a pediatric dermatologist and epidemiologist, needs to develop an independent, patient-oriented
research program in pediatric atopic dermatitis and chronic skin disease. Research: Atopic dermatitis, also
known as eczema, affects 20% of children and frequently overlaps with the critical period of cognitive
development that occurs in the first two decades of life. Although children with atopic dermatitis are more likely
to suffer from learning disabilities, inattention, and poor memory, the impact of atopic dermatitis on cognition
has not been rigorously examined. This project will: (1) test the hypothesis that atopic dermatitis, particularly
when severe or persistent, is both directly and indirectly associated with cognitive impairments in children, and
(2) identify modifiable risk factors that mediate the effects of atopic dermatitis on cognitive function. To achieve
these aims, Dr. Wan will use data from a longitudinal study of over 14,000 individuals followed from birth until
their 20s and also prospectively enroll a cohort of children with active atopic dermatitis. The results of this
project will fill critical gaps in knowledge about the impact of atopic dermatitis on cognition and carry significant
implications for clinical practice. Candidate: Dr. Wan earned her MD and MSCE degrees from the University of
Pennsylvania, where she also completed dermatology residency followed by pediatric dermatology fellowship
at the Children’s Hospital of Philadelphia. Dr. Wan is pursuing post-doctoral training in epidemiology with the
goal of becoming an R01-funded investigator and leader in pediatric dermatology research. Environment: Dr.
Wan will be primarily mentored by Dr. Joel Gelfand, a dermatologist and epidemiologist with expertise in
patient-oriented research in psoriasis and atopic dermatitis, and co-mentored by Dr. Susan Furth, a pediatric
nephrologist with expertise in chronic disease epidemiology and patient-oriented pediatric research, Dr. Kristin
Linn, a biostatistician with expertise in advanced statistical methods, and Dr. Nina Thomas, a pediatric
neuropsychologist with expertise in neurocognition research. She will be further advised by a complementary
committee of NIH-funded investigators in pediatric dermatology, neuropsychology, epidemiology, and atopic
dermatitis. With its robust research infrastructure and rich resources, Penn provides an ideal environment for
Dr. Wan’s research and career growth. Career Development: Dr. Wan’s proposal includes advanced training
in longitudinal data analysis and causal inference, neurocognitive development, and patient-reported outcome
measures, achieved through a combination of didactic coursework, practical research experience, and focused
mentorship. The support of a K23 award will enable Dr. Wan to launch a successful career as an independent
investigator dedicated to optimizing the health, social, and life outcomes for children with chronic skin disease.

Public health relevance
PROJECT NARRATIVE Nearly 10 million children in the U.S. live with atopic dermatitis, or eczema, a chronic disease of the skin that causes unbearable itch, disturbances in sleep, and decreased quality of life. Although children with atopic dermatitis are more likely to suffer from learning disabilities, inattention, and poor memory, little is known about the direct and indirect effects of atopic dermatitis on cognition, the mental processes involved in gaining knowledge and problem solving and which can significantly impact long-term health, social, and economic outcomes. In this project, I will characterize the relationship between atopic dermatitis and cognition, identify subgroups of children who may be at greatest risk for cognitive impairment, and determine modifiable risk factors that may be targeted to reduce the negative impact of atopic dermatitis on cognition.